Administrative Supplements for Equipment Purchases for Select NIGMS_Akala

Abstract of the Parent Grant Award
Project Summary: Triple-negative breast cancer (TNBC) accounts for approximately 15% of invasive breast
cancers and is associated with aggressive tumor biology, poor prognosis, resistance, visceral metastases and
earlier disease recurrence. TNBC is more common in younger women than in older women and in African-
American and Hispanic women. Platinum-based drugs showed higher sensitivity in TNBC compared to non-
TNBC patients and recently there has been a renewed interest for platinum therapy in TNBC, especially
combination of carboplatin with paclitaxel (PTX). Sacituzumab govitecan is made up of an anti–Trop-2 antibody
linked to the chemotherapy drug (SN-38) and was cleared by the FDA for TNBC patients who have undergone
at least two prior chemotherapies. The FDA granted an accelerated approval for the immunotherapy drug
atezolizumab in combination with chemotherapy (nab-paclitaxel) for the treatment of TNBC (for tumors positive
for PD-L1). Thus chemotherapy is important in the therapeutic management of TNBC even in the advent
of immunotherapy and targeted therapy. However, chemotherapies are known to cause fatal peripheral
neuropathy in addition to poor response, metastasis, relapse and development of multidrug resistance. The
goal of this application is the development of multifunctional targeted nanoparticles capable of achieving better
outcomes for TNBC patients: (a) targeted delivery of large doses of multiple drugs into cancer cells (per a single
biorecognition event compared to a single immunotargeted drug (e.g. sacituzumab govitecan-hziy)) to maximize
therapeutic effects while reducing systemic toxicity (off target toxicity); (b) EGFR-receptor targeted nanoparticles
that promote intracellular drug delivery and release and which can bypass multidrug resistant protein (p-
glycoprotein) which mediates efflux of drug molecules; (c) capable of long circulation without being sequestered
into the liver. EGFR is overexpressed by TNBC and literature is replete with examples of the use of cetuximab
in therapy by targeting EFGR. We hypothesize that the development of biodegradable polymeric
nanotechnology platform containing carboplatin and paclitaxel in the core and using cetuximab (tagged on
nanoparticle surface) as a targeting moiety will improve TNBC patients’ outcomes, unlike repeated
chemotherapy cycles with high doses of cytotoxic drugs. We hypothesize that the dual-loaded multifunctional
targeted nanoparticles will be active in vitro and show in vivo efficacy in mouse xenograft models of TNBC
positive tumors. Aim #1: Fabrication of polymeric dye-loaded and-paclitaxel and carboplatin-loaded stealth
hydrolysable crosslinked cetuximab surface-targeted polylactide (PLL) nanoparticles. Aim #2: Characterization
of anti-EGFR mAb (cetuximab) surface-targeted-PLL-nanoparticles containing carboplatin and paclitaxel in the
core. Aim #3: Biodistribution and efficacy studies in tumor-bearing mice. This work will bring to bear the
combined power of chemotherapeutic agents, molecular targeted therapy and nanotechnology to overcome
EGFR positive TNBC resistance and improve efficacy with minimal toxicity.

Public health relevance
The administrative supplement grant application for equipment purchase is based on the parent grant (Multifunctional Nanotechnology Platform for Triple Negative Breast Cancer Treatment (1 R16 GM145483-01)) to enable us purchase LC/MSD Bundle including LC/MSD and 1260 Infinity II LC System with OpenLAB CDS ChemStation Edition with a gift (by Agilent Technologies) of 1260 Infinity II Analytical Fraction Collector Maximum flow rate up to 10 mL/min (Quote #4261636) worth $21,100.58 under Academic Research Support Program Approval Code #20230130_020684). Purchasing the equipment will enable us to work without interruption occasioned by the breakdown of equipment; will put us in a position to more accurately quantify drugs loaded in our nanoparticles and in various tissues and brain following in vivo administration without relying on fluorescent dyes alone; will enable colleagues to benefit from the use of the equipment; and will enable us to train students and post docs and enjoy the large discount given to us.